Training in implementation science research to improve PrEP services for people at risk for HIV

PROJECT SUMMARY/ABSTRACT
Strategies for effective management of HIV care and prevention exist, however many evidence-based
interventions, such as Pre-exposure prophylaxis (PrEP), are not sufficiently scaled into practice, failing to reach
those most in need. Implementation science (IS) seeks to bridge the gap between research and practice to
ensure that evidence-based interventions are translated effectively at scale. IS methods are rapidly evolving;
trainees require mentors with dedicated time and research platforms to offer opportunities to learn and apply IS
methods as they work towards independent research careers. In this proposal Dr. Sheri Lippman, Associate
Professor in Residence at UCSF, proposes to: 1) expand her mentoring program, including formal training to
attain mentoring competencies, to improve the breathe and depth of the training she offers early career
scientists; 2) expand her own program of stakeholder-engaged IS research focused on means to improving
PrEP delivery to populations who are underserved through addressing clinic- and health system-based barriers
to care; and 3) provide early career scientists in UCSF programs and collaborating research institutions abroad
with a platform to train in IS methods. Dr. Lippman has built a research portfolio focused on social-behavioral
intervention development, supporting individuals and mobilizing communities to uptake HIV testing, prevention,
and care, mostly in Brazil and South Africa. The patient-oriented research in this K24 includes exploring
contextual domains from the Consolidated Framework for Implementation Research (CFIR) to characterize the
PrEP delivery context in clinics attending transgender women (TGW) in São Paulo, Brazil, and clinics attending
adolescent girls and young women (AGYW) in Agincourt, South Africa (Aim 1). The work then includes
stakeholder engaged processes to arrive at a proposed set of implementation strategies to improve PrEP
service delivery that facilitates PrEP uptake and maintenance based on the taxonomies from the Expert
Recommendations for Implementing Change (ERIC) Project (Aim 2). Finally, strategies will be piloted at one
clinic in each site to assess feasibility, acceptability, and monitoring processes to prepare for larger trials
(R01s) that evaluate whether selected strategies improve PrEP delivery, uptake, and maintenance. The
research focuses on PrEP delivery for TGW in Brazil and AGYW in South Africa as both are populations who
have high HIV incidence, poor engagement in HIV care, and low uptake of PrEP despite stated interest in use.
Dr. Lippman has extensive collaborations, including NIH-supported work, in both areas and can ensure
abundant opportunities for mentoring and stimulating new research among early career investigators in the US
and both countries. In sum, this K24 provides an opportunity for Dr. Lippman to expand her IS research to
address barriers to PrEP delivery in the clinic and health-system environment through implementation
strategies tailored to each site, concurrently building her mentoring program to ensure a pipeline of
investigators with skills to establish new careers and scientific inquiry in the burgeoning field of IS.

Public health relevance
PROJECT NARRATIVE HIV prevention and care interventions, including Pre-exposure Prophylaxis (PrEP), could effectively end the HIV epidemic, however, more research and training focused on implementation strategies to ensure PrEP is implemented effectively in public clinics is needed. This K24 provides protected time to Dr. Lippman to extend her current implementation research, broaden her mentoring program, and expand opportunities for early career investigators to engage in cutting edge implementation science research to address barriers to PrEP delivery in South Africa and Brazil. This work can improve PrEP delivery for health disparity populations with poor access to tailored HIV prevention and ensure a pipeline of trainees in the US and abroad who are well equipped in the application of implementation science approaches to stimulate new research and independent research careers.